Imaging Core

Core B will continue to serve the role it plays in our present PPG, while introducing two
novel CT imaging components for phenotyping embryonic arteriogenesis in mice and assessing permeability in
the setting of hindlimb ischemia in adult mice. All three projects extensively utilize Doppler flow velocity system
for blood flow measurements and high-resolution microCT imaging for arteriogenesis phenotyping, with
molecular, cellular and sub-organelle studies. For embryonic phenotyping, the Core will perform primary
services necessary for the desired imaging procedures such as catheterization and en bloc staining. The Core
will execute high-resolution microCT image acquisition, reconstruction, and analysis. These standardized
efforts will result in optimal image acquisition and processing, reduce variability and maximize data reliability,
while facilitating the translation of ideas from the bench to mice, and ultimately to humans. Core B procedures
will be performed by two research specialists under the direction of Dr. Zhenwu Zhuang.

Public health relevance
Coronary artery disease and peripheral artery disease are major causes of illness and death in developed nations. Poor arteriogenesis is a critical determinant of these diseases and in patients’ recovery after myocardial infarction. This PPG proposes to elucidate mechanism controlling blood vessel growth with the aims towards developing new therapeutic modalities for treatment of these diseases. These studies have the potential to identify new targets and new reagents for therapy, as well as to achieve a deeper understanding of the biology of arteriogenesis.